Implementing Mobile Technology for Unhealthy Alcohol Use in Emergency Departments

Project Summary
Unhealthy alcohol use (UAU) is one of the leading causes of premature mortality among adults in the United
States and has been increasing during the COVID-19 pandemic. UAU is more frequent among emergency
department (ED) patients than in the general population and ED visits involving alcohol consumption have
increased in recent years. Substance use has been described as the most important modifiable health
behavior in the ED, and the ED has been highlighted as a key setting to intervene with UAU individuals.
Consequently, health systems across the country need low burden, scalable ways to intervene with individuals
but often have limited time and resources. Mobile technologies have been suggested as a solution to assist
EDs in addressing UAU and one of the lowest burden, scalable approaches are text messaging interventions.
Text messaging interventions for ED and trauma patients and other populations have shown good outcomes,
including reductions in drinking quantity and frequency. Despite strong research support and promise for
scalability, there is little evidence that technology-based behavioral health interventions can be effectively
implemented into healthcare settings. There are few studies in which technology interventions for behavioral
health are put into real world healthcare settings; those that have been conducted show that the benefits seen
in randomized trials are often not realized. While EDs are promising venues for addressing UAU using text
messaging interventions, the process of providers making them available to patients in an efficient way within
already busy and overburdened ED workflows (i.e., implementation in real-world ED settings) and patients
adopting them remains a new area of research. This proposal builds on the longstanding collaboration of our
interdisciplinary team on the implementation of substance use screening and brief interventions in healthcare
settings. In response to the NIH Notice of Special Interest for Research in the Emergency Setting, we propose
to examine potential barriers and facilitators to staff offering and patients accepting a text messaging
intervention in the ED. We will then use a stakeholder-engaged Intervention Mapping process to develop a
multi-component implementation strategy for EDs. Finally, we will conduct a mixed method 2-arm cluster-
randomized pilot study in 4 EDs that serve ~13,000 UAU patients per year to assess the feasibility,
acceptability and preliminary effectiveness of the implementation strategy. The Integrated Promoting Action on
Research Implementation in Health Services (i-PARIHS) framework will guide study activities. Low burden
technology, like text messaging, along with targeted implementation support and strategies driven by identified
barriers and facilitators could sustain large-scale ED-based alcohol screening programs and provide much
needed support to patients who screen positive while reducing burden on EDs. The proposed study would be
the first to develop and test this targeted implementation strategy. This 2-year R21 will prepare for a future,
larger, fully-powered hybrid effectiveness-implementation trial.

Public health relevance
Project Narrative Scalable approaches are needed to support patients identified in the emergency department as unhealthy alcohol users and text messaging intervention approaches are a promising solution. However, the process of providers making text messing interventions for unhealthy alcohol use available to patients in an efficient way within already busy and overburdened ED workflows (i.e., implementation in real-world ED settings) and patients adopting them remains a new area of research. We will examine barriers and facilitators to the adoption of text messaging interventions for unhealthy alcohol use in emergency departments and use a stakeholder-engaged process to develop and test practical implementation strategies that could provide much needed support to patients who screen positive while reducing burden on emergency departments.